Role of cardiac clock misalignment in promoting arrhythmias in swine and donor human hearts

PROJECT ABSTRACT
Sudden cardiac arrest (SCA) due to malignant ventricular arrhythmias remains a major cause of mortality in
the US. While the majority of SCA patients have significant coronary artery disease (CAD), nearly one in three
patients present with lethal arrhythmias as their first and only manifestation of heart disease without prior
cardiovascular symptoms. Moreover, these arrhythmic events exhibit a diurnal variation but the mechanisms
responsible for this remain unclear. We hypothesize that chronic ischemia results in circadian misalignment
between ischemic and non-ischemic (healthy) regions and is a mechanism of increased cardiac arrhythmias
mediated by circadian phase shift in the intracellular calcium-calcineurin signaling. To test this hypothesis, the
proposed studies will use a combination of donor human hearts and swine model of chronic LAD stenosis that
develops ischemia with high frequency of SCA. We will employ optical mapping of ex vivo cardiac slices and in
vivo electrical mapping of intact hearts to establish whether a diurnal window of arrhythmia vulnerability exists
in swine with chronic LAD stenosis (Aim 1). Next, we will investigate the extent to which cardiac circadian
misalignment exists in swine with chronic LAD stenosis and determine whether pharmacological circadian
realignment can attenuate incidence of arrhythmias and SCA (Aim 2). Finally, we will use donor human hearts
to validate the findings from swine studies (Aim 3). Successful completion of the proposed studies will provide
unique insight regarding the impact of circadian misalignment on arrhythmia vulnerability and illuminate
opportunities for pharmacological interventions to manage, prevent, or even restore the loss of cardiac
circadian alignment and consequently attenuate time-of-day incidence of cardiac arrhythmias and SCA.

Public health relevance
PROJECT NARRATIVE Sudden cardiac arrest (SCA), life-threatening arrhythmias as well as onset of adverse ischemic events exhibit increased incidence in the early hours of the morning, however the mechanisms are not well understood. The proposed experiments will determine whether cardiac circadian disruption is a viable therapeutic target for arrhythmias. Successful completion of this work will illuminate opportunities for pharmacological interventions to attenuate time-of-day incidence of cardiac arrhythmias and SCA.